Towards a complete characterization of the metastasis founder clones in colorectal cancer

The mechanistic basis of metastasis formation in humans remains elusive. We do not know whether metastases
are formed by random disseminated cells, or whether molecularly defined metastatic clones with superior ability
to colonize specific organs exist. In metastasis experiments in mice, (rare) subpopulations of cells with increased
metastatic potential have been shown to exist. This potential is mitotically heritable and associated with specific
gene expression programs. In humans, similarly compelling data does not exist, and a unified theory of
metastasis that harmonizes observations in animals and humans and makes testable predictions with clinical
relevance is still missing. Using phylogenetic analysis of hundreds of human colorectal cancer samples, we have
recently shown that anatomically distinct distant metastases are typically formed by only one primary tumor
subpopulation (“metastasis founder clone”). Here, we propose a novel experimental design that aims to identify
the molecular traits of metastasis founder clones in humans. In specific aim 1, we will conduct a rigorous search
for recurrent gene expression patterns in metastasis founder clones. We will collect grid biopsies from newly
resected primary colorectal cancers and matched synchronous liver metastases, reconstruct evolutionary trees
from microsatellite mutation data and precisely annotate metastasis founder areas vis-à-vis the remainder of the
primary tumor (“bystander areas”). Then, we will perform RNA sequencing to identify founder-specific gene
expression patterns across 70 patients, with the goal of defining a universal “founder signature” that identifies
cell populations with superior metastatic ability within a primary tumor. In specific aim 2, we will investigate
mitotically heritable molecular alterations that could potentially give rise to a metastasis-enabling gene
expression signature. We prioritize somatic copy number alterations (SCNAs) and DNA methylation patterns as
candidates for such alterations, but to be comprehensive, we will also evaluate driver mutations. We will perform
shallow whole genome, exome and reduced representation bisulfite sequencing in founders, selected
bystanders, and matched metastases to determine whether founders are enriched for a specific subset of
SCNAs, driver mutations and/or methylation changes. In specific aim 3, we will validate and mechanistically
explore the biological properties of metastasis founder clones with xenotransplanation assays of patient-derived
organoids (PDOs). In Aim 3A, we will deploy PDO technology to test the hypothesis that PDOs from metastasis
founder areas are more likely to metastasize to the mouse liver than PDOs derived from bystander areas,
providing an independent method for corroborating our human results. In Aim 3B, we will use the PDO
xenotransplantation system to explore the biological function of genes highlighted as metastasis-relevant in aims
1 and 2 via loss- and gain-of-function genetic screens. This in vivo experimental framework will enable in depth
mechanistic follow-up on leads gained in Aims 1 and 2. In total, this proposal outlines the first steps toward the
urgent clinical imperative of identifying the molecular features of metastasis founder clones in colorectal cancer.

Public health relevance
Despite decades-long research, the mechanistic basis of metastasis formation in humans remains elusive. We have recently generated strong evidence to support the existence of a subpopulation of primary tumor cells with superior ability to colonize specific organs (the “metastasis founder clone”). Here, we propose a novel experimental design to identify the molecular characteristic of metastasis founder clones in humans, followed by detailed mechanistic follow-up of novel gene targets in xenotransplantation assays of patient-derived organoids.